Targeting Integrin Pathways by GLPG-0187 in Medulloblastoma

Project Summary
Medulloblastoma (MB) is the most malignant pediatric brain tumor. Current treatments for
MB patients include surgery, radiotherapy and chemotherapy but unfortunately, many
patients remain incurable or suffer significant neurological, intellectual and physical
disabilities. Therefore, novel therapeutic approaches are urgently needed. The integrin
family of cell adhesion receptors contributes to multiple cellular functions crucial to tumor
initiation, progression and metastasis. However, it remains unknown whether targeting
integrin signaling has therapeutic benefits in MB. We recently found expression of 1-
integrin (ITGB1) is overexpressed in MB tissues. Moreover, GLPG-0187, a broad-
spectrum integrin receptor antagonist, significantly inhibits MB cell growth in vitro and in
vivo. Based on our novel results, we hypothesize that targeting integrin signaling by
GLPG-0187 may lead to novel therapies for MB patients. To test this, we propose to
determine the action mechanisms of GLPG-0187’s in MB, and to determine whether
GLPG-0187 inhibits tumor growth in MB preclinical animal models. The anticipated results
of these studies are functional and mechanistic evaluations for the efficacy of GLPG-0187
in MB, which will accelerate the development of potential therapeutics into clinic for MB.

Public health relevance
Project Narrative The overall purpose of this proposal is to determine the action mechanism of a broad- spectrum integrin receptor antagonist GLPG-0187 in medulloblastoma and its efficacy in medulloblastoma preclinical mouse models. Successful outcome of this project will promote development of novel therapeutics into clinic for medulloblastoma patients.